Advancing Success & Developmental Outcomes in Autism Spectrum Disorder through Analysis of Secondary Data (ASD3 Outcomes Project)

Project Abstract
Autistic children experience some of the lowest health care quality and highest unmet needs of any
pediatric chronic condition. Additionally, disparities persist in service use and life course outcomes among
autistic people. These problems exist because (1) we have not adequately assessed which outcomes are
most essential for autistic children and their caregivers, and (2) few large-scale studies have assessed
which individual and family factors, service use factors, and local/state environmental features are
associated with optimal and suboptimal health outcomes. The proposed project, Advancing Success and
Developmental Outcomes in Autism Spectrum Disorder through the Analysis of Secondary Data (ASD3
Outcomes), will fill these evidence gaps by linking multiple large, population-based data sets providing
rich information on various factors driving health outcomes for autistic children. By the end of this project,
we will have generated actionable evidence to guide national and state-level strategies for improving
health outcomes for autistic children ages 1–17 years. Leveraging cutting-edge data science
methodologies including multi-source data harmonization and deep learning, this initiative will identify the
most salient predictors of optimal and suboptimal outcomes among children and youth, examine
geographic and demographic disparities in these outcomes, inform system-level interventions, and
advance evidence-based policy change to improve health for autistic individuals.
First, we will assemble a community advisory panel of autistic youth and adults, parents and caregivers,
and health and educational providers, and a technical advisory panel of autism and data science
researchers. We will use the panelists’ expertise to identify key health and educational outcomes that can
be measured in Medicaid claims data in all 50 states, the National Survey of Children’s Health (NSCH) in
all 50 states, and/or Early Intervention state data (HI, IN, MN, OR, VT).
Next, we will use the NSCH to create state-level, age-specific Autism Quality Indices that measure factors
driving health outcomes for autistic children at different developmental stages. We will apply these
indices, along with child-level demographic markers, neighborhood measures (using the Child
Opportunity Index 3.0), and other state health and education systems variables, to model key outcomes
in Medicaid Claims and State Early Intervention data, through interpretable machine and deep learning
models.
Finally, we will translate evidence into action by harnessing the collective expertise of our community and
technical advisory panels to develop recommendations based on the community-engaged and data-
driven findings generated. These efforts will produce actionable insights to guide policy, programs, and
practice that optimize health outcomes for autistic children and their families nationwide. We will
disseminate this work broadly.